Administrative Core: U19

Admin Core Project Summary:
This innovative integrated systems biology application seeks to delineate the complex host/pathogen interactions
occurring at the alveolar level that lead to unsuccessful response to therapy in serious pneumonia. The
Administrative Core will be responsible for managing, coordinating, and supervising the entire range of SCRIPT
Systems Biology Center activities. As such, the Administrative Core will intersect with all internal SCRIPT
investigators as well as the NIAID sponsoring agency, other Systems Biology Centers, and the broader infectious
diseases and pulmonary/critical care scientific communities. The SCRIPT Systems Biology Center is intentionally
multidisciplinary, increasing the complexity of interactions and mandating a centralized approach to facilitate
accomplishing the goals of this Systems Biology Center. The Administrative Core will accomplish these
objectives in three interrelated specific aims: AIM 1. To provide the administrative and organizational
infrastructure to facilitate accomplishment of the SCRIPT goals within proposed timelines, and to disseminate
the output of the Research Projects and Cores. This will include the submission of SCRIPT Systems Biology
Center output to NIAID-directed public databases/repositories. AIM 2. To coordinate and integrate the two
SCRIPT Systems Biology Center Research Projects. AIM 3. To organize local and external outreach programs
to promote a systems biology approach to infectious pneumonia. This includes integration of the SCRIPT
Systems Biology Center into current local training programs, submission of an application to Gordon Research
Conference or similar conference for a research symposium on a systems biology approach to pneumonia and
a proposal to the American Thoracic Society for a post graduate course on Systems Biology Approaches to
Pneumonia. The major premise of the SCRIPT Systems Biology Center research agenda is an iterative approach
to host/pathogen interactions based on results of high throughput omics approaches and modeling of the results.
We therefore expect that prior results will drive subsequent experiments. Integration and facilitation of these
subsequent experiments between the different Cores and investigators will be the primary responsibility of the
Administrative Core. Investigators in the Administrative Core will also ensure that data generated by the Projects
and Cores are disseminated in formats that are useful to the larger community of pneumonia researchers.

Public health relevance
Project Narrative It is not required per instructions stated on the Funding Opportunity Announcement RFA-AI-16-080, Section IV. Application and Submission Information, Administrative Core, Research & Related Other Project Information (Administrative Core), “Project Narrative: Do not complete”.